Administrative Core

The Administrative Core of the Membrane Protein Structural Dynamics (MPSD) Consortium is set-up to provide the necessary leadership and administrative support structure to ensure optimal performance and effective coordination of the MPSD Consortium activities. This Core is the hub of all activities and will provide strong scientific leadership and oversight. The function of the Administrative Core is to achieve five objectives: (1) facilitate interactions among Projects and Cores; (2) provide necessary administrative assistance to MPSD Consortium investigators and participating institutions; (3) manage all MPSD Consortium finances; (4) convene all necessary MPSD meetings, including Executive Committee meetings, monthly scientific meetings, annual External Advisory Committee meetings and annual retreats; and (5) provide day-to-day logistical coordination for the Consortium. However, as one of the key lessons learned in the previous funding period, the leadership provided by the Core cannot come at the cost of micromanaging individual projects or teams. Core A will continue to ensure compliance with all institutional, governmental and NIGMS-specific regulations and requirements, including timely communication and consultation with NIGMS staff. Other critical management objectives have been, during Phase I, to make decisions about allocation (and reallocation) of resources, project expectations and progress, and providing a structure to recruit new talent into the Center. The present scientific line-up planned for Phase II of the consortium should ensure the successful completion of our 10 year scientific plan, securing the highest possible impact of the Center's scientific discovery, education, and public outreach activities.

Public health relevance
Not Applicable